Addressing Fertility Information Needs and Fertility-related Distress among Female Adult Survivors of Childhood Cancer

Impaired fertility is a highly distressing, under-addressed, late effect of cancer and cancer treatment among
female adult survivors of childhood cancer. Many female survivors are uncertain about their fertility status and
report unmet fertility information needs and fertility-related distress. For those who desire biological children,
overestimation of risk for impaired fertility may cause unnecessary emotional and relational distress.
Underestimation may lead to a missed opportunity to pursue having biological children due to factors such as
premature ovarian insufficiency. Yet, to date, fertility-related information needs and distress remain largely
unaddressed in this population. Following the ORBIT Model for behavioral intervention development, the
proposed study seeks to design and refine a behavioral intervention to address unmet fertility-related information
needs and fertility-related distress among female adult survivors of childhood cancer (aged 18-44). Phase I of
the study will involve conducting individual interviews with female adult survivors of childhood cancer (N=20) and
medical providers who care for this population (N=10) to inform the development of a preliminary, manualized,
intervention. Based on existing literature and feedback from experts in behavioral interventions for cancer
survivors, adult survivors of childhood cancer, and infertility, it is anticipated that an intervention combining
strategies from Patient Activation Theory and Acceptance and Commitment Therapy will be developed.
Intervention development is flexible and will be tailored based on feedback received from stakeholders. In Phase
2, preliminary intervention content will be delivered to a small sample of the target population (N=30). Feasibility
and acceptability, as well as examination of pre- to post-intervention patterns of change in intervention targets
(primary: fertility health knowledge, fertility-related distress; secondary: psychological flexibility, patient
activation, and self-efficacy), will be assessed and utilized to further refine the intervention (e.g., intervention
strategies, intervention length, and delivery modality). In line with the National Cancer Institute's priority research
area focused on cancer survivorship, the overall goal of the fellowship is to support Dr. Stalls to develop expertise
that will enable her to become a leading clinical researcher in the development and evaluation of behavioral
interventions to address reproductive and sexual health late effects among cancer survivors. To do so requires
a unique combination of knowledge and skills in the areas of, 1) Reproductive and Sexual Health, 2) Behavioral
Intervention Development and Evaluation, and 3) Professional Development. Training in these areas will be
accomplished through guidance from expert sponsors and collaborators as well as the many resources and
training opportunities offered at Duke University. Completion of this fellowship would not only advance the
survivorship literature in this area and propel Dr. Stalls toward her career goals, but help address the significant
gap in well-trained clinical researchers who are equipped to address these highly personal and time-sensitive
reproductive and sexual health late effects of cancer and cancer treatment.

Public health relevance
Project Narrative Adult survivors of childhood cancer are a growing population who face a number of long-term and late effects secondary to their cancer treatment, which have the potential to profoundly impact their future health, quality of life, and achievement of life goals. This project will examine the initial feasibility, acceptability, and pre- to post- intervention patterns of change in treatment targets of a novel behavioral intervention aiming to address fertility-related information needs and fertility-related distress among adult survivors of childhood cancer. Although this project is focused on the late effect of impaired fertility, the intervention developed through this study has the potential to produce significant public health benefits: it could be applied to address other late effects in this population, which if left untreated, may lead to greater health complications in this growing population later in life.